Extracellular drivers of myocyte stiffening in diastolic heart disease

Diastolic heart disease, DHD, is a leading cause of death and disability worldwide. With no FDA approved
therapies to improve diastolic dysfunction, the NIH has placed special emphasis on collaborative initiatives
between basic scientists and clinicians focusing on understanding the molecular mechanism of diastolic
heart failure. Cardiac stiffening is a hallmark of diastolic dysfunction and occurs through mechanisms
intrinsic to both cardiomyocytes and extracellular matrix, ECM. With the majority of heart failure therapies
designed to target cardiomyocytes and not, the influence of pathologically remodeled ECM on
cardiomyocyte and cardiac function is of particular clinical importance. In this proposal we leverage a
recently developed cardiac preparation to probe the mechanical properties of the DHD ECM and determine
its influence of cardiomyocyte diastolic function. Using an established model of DHD, the obese ZSF1 rat,
we determine the degree to which myocardial stiffening depends on cardiomyocyte and ECM stiffening
respectively and quantify the structural and compositional changes of ECM in hypertension and DHD. In
Aim 2 we determine the influence of DHD ECM on cardiomyocyte structure and function. By maturing
cardiac stem cells in decellularized ECM from normal, hypertensive and DHD hearts, we determine the
influence of the DHD ECM on cardiomyocyte structure and function. With a custom-adapted mounting
system, we will be able to measure diastolic performance of cardiac organoids grown in either normal or
DHD ECM. Consistent with our preliminary data, we expect to observe that DHD ECM drives
cardiomyocyte hypertrophy, enhanced contractility, and impaired relaxation. These results indicate that the
DHD ECM can signal cardiomyocytes to adopt characteristics of diastolic heart disease.